Investigating the role of N6-methyladenosine in the development of drug resistance in glioblastoma

PROJECT SUMMARY
RNA chemical modifications are critical regulators of gene expression through regulation of RNA stability,
splicing, translation, structure, and localization. Because of their important roles in several biological pathways,
RNA modifications are frequently implicated in disease. N6-methyladenosine (m6A), the most prevalent internal
RNA modification in eukaryotic messenger RNA (mRNA), has been extensively studied and implicated in a
wide-array of human diseases, most notably cancer. Due to the established role of m6A in cancer, m6A and its
associated machinery have been proposed as potential diagnostic and predictive biomarkers and therapeutic
targets. Although the role of m6A in several cancer is relatively well-established, its regulatory role in
glioblastoma (GBM) pathogenesis remains largely unclear. GBM, a grade IV glioma tumor, is the most
common primary malignant brain tumor. GBM is a devastating disease associated with poor patient prognosis,
limited therapeutic options, and frequent recurrence with acquired therapy resistance. Because m6A has been
extensively demonstrated to play an important regulatory role in cancer, the goal of my proposal is to
characterize molecular mechanisms by which m6A regulates GBM pathogenesis, and uncover how
manipulation of m6A regulation may improve GBM treatment. The first portion of my research will examine the
mechanism by which m6A post-transcriptionally regulates MGMT, a critical biomarker and predictor of
chemotherapy response in GBM. To accomplish this, I will map m6A sites on MGMT mRNA, determine how
disrupting m6A installation on MGMT affects MGMT expression and stability, and identify reader proteins which
facilitate this effect. I will then determine the consequences of this regulatory mechanism on chemoresistance
of glioma cells. In the second portion of my research, building upon preliminary RNA sequencing data, I will
investigate mechanisms transcriptome-wide as to how m6A regulates the transcriptome of glioma cells in
response to chronic treatment with an alkylating agent. To accomplish this, in chemoresistant glioma cells, I will
(1) map m6A sites, (2) temporally sequence RNAs to measure the effect of m6A perturbation on RNA stability,
and (3) sequence the interactome of canonical downstream regulators m6A-modified transcripts. Together,
these complementary studies will increase our understanding of mechanisms by which m6A regulates GBM
pathogenesis and reveal vulnerabilities that can be targeted with m6A-mediated therapeutics.

Public health relevance
PROJECT NARRATIVE My proposed work investigates the role of the RNA chemical modification N6-methyladenosine (m6A) in glioblastoma pathogenesis and therapeutic resistance. My preliminary data suggests that m6A regulates expression of a critical glioblastoma predive biomarker and that inhibiting m6A using a small-molecule may inhibit tumorigenesis and promote chemosensitivity in glioma cells. My proposed research will expand upon these preliminary findings and characterize the molecular mechanisms involved to ultimately increase our understanding of the role of m6A in GBM pathogenesis and therapeutic response.